Stalled capillary flow: a novel mechanism for hypoperfusion in Alzheimer disease

Project Summary / Abstract We seek to investigate the agent-based participation of machine learning (ML) models in an existing crowdsourcing system, which could substantially speed up biomedical image analysis without loss of data quality for Aims 2-4 in our R01 research. We encountered an analytic bottleneck in our prior R01-supported work, which seeks to reveal mechanisms that underlie capillary stalling in the brain and requires quantifying stall rates from 2PEF (2-photon excited fluorescence) image stacks. To address this, we partnered with the Human Computation Institute (HCI) to crowdsource the analysis using the online citizen science platform Stall Catchers, which has reduced the time to analyze a typical dataset from many months to just a few weeks. Beyond enabling several published results, 35,000 Stall Catchers volunteers have produced over 1.4 million high-quality “crowd” annotations, which served as a rich training set in a recent machine learning competition that led to the creation of fifty distinct ML models exhibiting a broad distribution of sensitivity and bias. None of these models, by itself, meets our stringent analytic requirements. However, if we could endow these models with sufficient agency to participate as bonafide Stall Catchers players, then we could test the hypothesis that hybrid (human/machine) ensembles will achieve the same data quality as human-only ensembles when answers are combined using our existing “wisdom of the crowd” algorithm. Developing an open source toolkit for transforming ML models into citizen science “bots” would enable a direct pathway for effectively integrating even substandard ML models into an existing crowd-powered analytic pipeline without requiring intensive re-engineering. Accelerating biomedical data analysis in this way could allow other biomedical researchers to derive immediate value from smaller training sets and investigate more hypotheses using less time and resources. This project could enable a low-overhead pathway for semi-automation using imperfect ML models, which could leverage ML sooner while reducing reliance on human cognitive resources, and provide a pathway for achieving fully automated analyses as improved ML models are added to the crowd as CitSci bots. Success in this pursuit would allow us to incorporate full-time CitSci bots into Stall Catchers, which could double the number of capillary stalling studies we can conduct in a given year toward elucidating a more complete mechanistic model of capillary stalling. This would speed up our ability to identify a targeted intervention with reduced side effects that could alleviate cognitive impairments in implicated dementias, such as Alzheimer’s disease while contributing to the advancement of hybrid intelligence methods with broad utility for biomedical data analysis.

Public health relevance
Narrative Due to an analytic bottleneck that couldn’t be solved using automation, we used citizen science to crowdsource the analysis of capillary stalling in direct support of aims in our R01-supported Alzheimer’s research. Having collected 1.4 million crowd-generated labels we recently ran a machine learning (ML) competition, resulting in 50 new ML models, which perform well but do not meet our data quality standards. We now propose to investigate a new mode of human/machine collaboration, which would allow these models to participate directly as autonomous agents alongside humans in our crowdsourcing systems, which could speed up our data analysis, reduce reliance on human annotators, and improve data quality, while providing a proof of concept and open source tools to reduce barriers and increase opportunities for using ML for biomedical data analysis.